Core C: Biometrics

Abstract
The Biometrics Core provides the infrastructure that facilitates an organized, synergistic, and centralized
approach to statistics in HIV research for the UW/Fred Hutch CFAR members, with an emphasis on providing
support and training to junior investigators. The services provided by the Core help ensure rigor and
reproducibility in HIV research conducted by CFAR investigators. In addition to standard statistical support, the
Core provides advanced statistical methods and expertise in the design, conduct and analysis of clinical research
and laboratory studies to CFAR investigators. This includes the development of novel methods when standard
approaches are not adequate or optimal by providing a crucial link between CFAR biomedical researchers and
the large number of biostatistics and other quantitative sciences faculty at the University of Washington and the
Fred Hutch who are developing new methods for HIV research. In addition, the CFAR clinical, behavioral, and
laboratory researchers using the Core provide datasets for analysis, which motivate the development of new
quantitative methods by biostatisticians, biomathematicians and bioinformaticists at UW and Fred Hutch. Hence,
this link benefits CFAR members as well as academic quantitative science researchers. Finally, the Core
provides training in both standard statistical methods as well as more advanced topics involving specialized
method for complex new data types and provides an opportunity for the next generation of quantitative
researchers and leaders. Specifically, methods for both microbiome analysis and viral dynamics studies are not
well established so that results from analysis using standard methods are far from rigorous and reproducible.
Thus the need for further methods development in this area is crucial. Finally, the quantitative support we provide
contributes to the innovative, impactful, multidisciplinary and global research of all members who collaborate
with our Core. To promote and facilitate these multidisciplinary interactions, the Biometrics Core: i) provides
statistical, mathematical and informatics collaboration and consultation on study design, forms design, evaluation
and pre-testing, data analysis, interpretation and reporting; coordinates Data Safety and Monitoring Boards;
provides data management services (Aim 1); ii) serves as a liaison between the Core user with advanced
quantitative needs and experts from the UW Departments of Biostatistics, Statistics, Mathematics, and Applied
Mathematics, and the Fred Hutch Program in Biostatistics and Biomathematics (Aims 1 and 2); 3) develops,
adapts and/or implements new or novel statistical and mathematical methods as dictated by the needs of CFAR
members and their projects (Aim 2); 4) sponsors and conducts training activities designed to disseminate
statistical skills to CFAR investigators, inform the HIV researchers about services available from the Biometrics
Core, and introduce novel quantitative approaches to the UW/ Fred Hutch CFAR community (Aim 3); and 5)
organizes activities that promote communication among existing statisticians in HIV research and interest from
other biostatisticians that can be recruited to meet the growing demand of HIV research (All Aims).